Training in the Cognitive Neuroscience of Communication

Project Summary/Abstract
Disorders that affect communication have an enormous personal, societal, and economic impact. These
conditions (e.g. aphasia, developmental language disorder, dyslexia, deafness and hearing impairment, autism)
can be better addressed through a more complete understanding of the neural systems that support typical
communication. To make progress in assessment and treatment of these conditions, the next generation of
scientists needs to not only understand the underlying neural bases of disordered communication, but also how
to translate research from the laboratory to the clinic. Additionally, research on communication disorders must
incorporate not just historical knowledge but also the perspectives of the communities affected by these
conditions. Hard-won lessons teach us that meaningful change relies on community-engaged research, where
researchers and stakeholders collaborate to identify questions and build mutual trust. The current proposal, a
renewal of Cognitive Neuroscience of Communication training program, will recruit a total of thirteen predoctoral
trainees and five postdoctoral trainees, each serving a two-year traineeship, and equip them with specific skills
and competencies crucial for research careers. Trainees from Psychology and Speech, Language, and Hearing
Sciences will receive targeted instruction in cognitive neuroscience, with an emphasis on neuroimaging methods,
and will learn to apply those skills in trainee-led, mentored research projects. Further, training will emphasize the
application of basic research, and trainees will interact not only with scientists who are experts in communication
disorders, but also clinicians and community stakeholders, including those that are affected by aphasia, dyslexia,
and autism, among other conditions. Individualized development plans support these training themes, reinforcing
skills in community-engaged research, individual differences methods, and computational skills. Our mentor
team, drawn from faculty in Speech, Language, and Hearing Sciences and three different degree programs in
Psychology, has substantial expertise in a variety of neuroimaging and neuromodulation methods (e.g. fMRI,
fNIRS, TMS/tDCS, EEG/ERP) and has conducted impactful research on a range of communication disorders
(e.g. aphasia, hearing loss, dyslexia, developmental language disorder, autism). This training program will
produce a cohort of scholars who are poised to make significant progress in the study of communication.

Public health relevance
Project Narrative Communication disorders affect millions of individuals, with significant impacts in terms of disability and quality of life. The development of assessment and treatment strategies for these disorders requires that the next generation of researchers understand the mechanisms underlying these communication disorders; however, progress has been hampered by a shortage of clinically-knowledgeable communication scientists with the methodological skills required to study these underlying mechanisms. The current training plan seeks to prepare predoctoral and postdoctoral trainees studying the cognitive neuroscience of communication by supplying them with the necessary methodological expertise and tools to conduct and disseminate impactful research on communication disorders while making meaningful connections between trainees and the clinical populations they study.